Administrative Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Administrative Core (Core A)
The administrative core will provide organizational leadership to the Center consortium, and thereby integrate
the many component aspects of the consortium into a unified programmatic whole. One responsibility of the core
is intellectual leadership and governance. Specifically, the administrative core manages systems that assure
consortium leadership that is a collaboration of the NBER co-PIs and NIA staff and informed by the scientific
community and an External Advisory Panel. A second responsibility is centralized administrative,
communication, and research support. The many administrative and coordinating functions of the core include
managing a Center website for sharing activities, events, resources, and products; monitoring and compiling
information about the activities and products of the various projects; managing finances and personnel; sharing
program information both internally and publicly; coordinating shared resources; and linking researchers to the
training opportunities, data resources, technical expertise, and dissemination mechanisms available through the
Center. A third activity is establishing and managing an early career scholars' program. As the organizational
hub for the consortium, the administrative core is also directly involved in supporting the research project
solicitation and selection processes of the research project core, the outreach and convening activities of the
stakeholder engagement core, and the dissemination and meeting activities of the translation core. The
administrative core also administers a program tracking plan that monitors progress on the clearly specified
short-term and long-term metrics and milestones associated with each Core as well as the productivity metrics
of research projects conducted under the companion program announcement.